Balancing Airway Progenitor versus Progeny: a Pathway from Mitochondria

PROJECT SUMMARY/ABSTRACT
The airway is composed of luminal cells such as club and ciliated cells that moisturize and clean the
airway, respectively. They are lined by basal cells that serve as progenitors for luminal cells in normal turnover
and injury repair. Proper balance of progenitor and luminal/differentiated cell ratio is critical for airway function.
While many genes have been identified that control individual cell fate, knowledge gaps remain in how the ratio
of progenitors and differentiated cells are globally regulated. In this study, we will investigate how airway cell
ratio is established in development, maintained in homeostasis and restored following injury.
Our entry point is Lon protease 1 (LONP1), an ATP-dependent serine protease that functions in the
mitochondria matrix to degrade oxidized and misfolded proteins, thereby control protein quality and
mitochondria health. Mutations in LONP1 has been identified in congenital diaphragmatic hernia (CDH)
patients. CDH carries a high mortality rate associated with lung hypoplasia and pulmonary hypertension. To
address if Lonp1 plays a role in lung, we inactivated it in the developing lung epithelium and mesenchyme.
While the mesenchymal mutants survived to adult with no discernable phenotype, the epithelial mutants
exhibited lung hypoplasia and died at birth. Unexpectedly, these mutants also exhibited a striking increase of
basal cells at the expense of club and ciliated cells. Further preliminary data revealed an increase in integrated
stress response (ISR) pathway genes, and an increase of KDM6B, a key histone demethylase. In this study,
we will investigate the role of this mitochondria factor LONP1 in controlling airway cell fate balance via ISR
pathway (Aim 1), chromatin regulators (Aim 2) and in adult airway homeostasis and following influenza-
induced injury (Aim 3). Our findings will delineate a novel pathway from a mitochondria protease to ER ISR to
nuclear chromatin regulators in the fundamental control of airway cell fate.

Public health relevance
NARRATIVE The human airway is composed of multiple cell types each with specialized role. Proper balance of the airway cell types, especially between differentiated luminal cells and basal progenitor cells is essential for airway maintenance and function. In this study, we will address the fundamental question of how airway progenitor versus progeny balance is established during lung formation, maintained in the adult during normal turnover, and restored following lung injury such as viral infection.